Center for Innovative NeuroTech Advancement (CINTA) - Administrative Core

Abstract: ADMINISTRATIVE CORE
The Administrative Core is the central element of the proposed hub and responsible for leadership,
management, and oversight of the other Cores with input from the Steering Committee. CIMIT has extensive
experience in setting up Administrative Cores in its previous work as the Point-of-Care Technology Research
Center in Primary Care, as the Coordinating Center for POCTRN, and as the primary architect for the
administrative structure for RADx Tech. The Administrative Core will provide governance, set policy, and
continuously improve the efficiency of CINTA based on feedback from the Steering Committee, real time
metrics, and achievement of benchmarks. The Steering Committee will be part of the Administrative Core and
charged with providing CINTA leadership with strategic oversight and recommendations for accelerating
commercial translation and clinical impact. The CINTA Coordination Team within the Administrative Core,
composed of the PI, Co-PI, and Core leads, will work closely with the Steering Committee to make all major
decisions. Dr. Schachter has drawn on his career-long interests in neurology, technology, and patient
advocacy to receive commitments from national leaders to join the Steering Committee, who reflect a diverse
range of expertise corresponding to areas of interest of the NIH Participating Organizations, as well as relevant
life experiences and work with disadvantaged communities. To create a patient-centered focus for CINTA, the
Administrative Core will create a Consumer Advisory Board within the Administrative Core to convey the voice
of the patient to CINTA. The Administrative Core will work with the Outreach Core to develop and implement
clinical needs assessments in advance of each solicitation to identify unmet needs in nervous system disorders
where technology-based solutions would have the highest impact. Utilizing the information gleaned from the
needs assessments. The Administrative Core will then create, post, and disseminate a solicitation. CINTA will
leverage CIMIT’s extensive experience with solicitations and subproject support to identify the most promising
technologies and provide milestone-driven funding, resources, and relevant expertise to assist innovators in
rapidly moving technologies to human-grade prototypes. To support these processes and roles, CIMIT created
and has continuously improved and utilized, a secure, web-based infrastructure to enable efficient and
effective operations. This infrastructure consists of: 1) the CoLab platform, which is used to manage
solicitations, and specifically the flow of applications through the multi-stage, interactive project selection
process, and 2) the GAITS platform, which helps project teams successfully navigate and accelerate the
challenging journey of innovation in healthcare. CINTA will follow all applicable NIH guidelines and will abide
by NIH standards for confidentiality, conflict of interest, and data security. CINTA is committed to embedding
principles of diversity, equity, inclusion, as represented by Steering Committee membership, the CINTA
Coordination Team, as well as the voice of the patient, into the work of the Administrative Core.